Dissection of the TORC1 Signaling Network in Yeast

Summary
The Target of Rapamycin kinase Complex I (TORC1) is a central hub in the cell growth and metabolic control
network of eukaryotes. Studies carried out over the last twenty years have identified numerous components in
the TORC1 pathway, and uncovered the important role that TORC1 plays in diseases and disorders such as
cancer, epilepsy, diabetes, depression, and aging. However, even as our understanding of TORC1 signaling
matures, it remains unclear how TORC1 functions at the systems level. Why are there so many TORC1
regulators--some with seemingly identical functions? And how are the signals transmitted through individual
TORC1 regulators integrated to ensure that cell growth and metabolism remain balanced across conditions?
Over the past 12 years we have addressed these and related questions by building up a detailed, network level,
model of TORC1 signaling in the simple model organism Saccharomyces cerevisiae. Our work has led to the
identification of several new proteins involved in TORC1 regulation, but perhaps most importantly has (i) shown
that TORC1 is driven into different signaling states in different conditions to optimize the activity of hundreds of
downstream targets and (ii) uncovered that the cAMP dependent protein kinase (PKA) pathway acts in parallel
with TORC1 to tune the threshold and timing of the cell growth response. Most recently, we discovered that
TORC1 is pushed into a unique, intermediate signaling state in poor nutrient conditions, where it activates targets
involved in amino acid transport and metabolism, and slows growth via a single transcriptional repressor, but
other TORC1 outputs match those seen in ideal growth conditions. Building on this framework, we now propose
an ambitious and integrated set of experiments to: (1) Determine how TORC1 is driven into the intermediate
signaling state in poor nutrient conditions; (2) Determine how TORC1 signaling is altered, as conditions get
worse, to slow growth further and tune metabolism; and (3) Identify the missing layers of TORC1 regulation that
push cells into quiescence/arrest during complete starvation. To do this, we will map the impact that known and
putative TORC1 regulators have on signaling across a wide range of conditions using several reporters of
TORC1 activity, live cell microscopy, and phosphoproteomics. We will also study the impact that over 100 newly
identified TORC1 pathway interactors have on TORC1 and global signaling across conditions, using high-
throughput microscopy, phosphoproteomics, transcriptomics, and detailed follow up experiments. The resulting
model should serve as a paradigm for future systems level studies of human TORC1 signaling and will shed light
on differences between yeast and human TORC1 signaling network, opening the door to creating new (and
sorely needed) antifungal compounds.

Public health relevance
Project Narrative The proposed research is relevant to public health since it focuses on dissecting the mechanisms underlying the regulation of a highly conserved signaling complex (TORC1) known to play an important role in cancer development, diabetes, obesity and depression. The work may also reveal differences between the pathways that control cell growth in lower eukaryotes and humans, opening the door to creating drugs that can selectively block the growth of fungal pathogens.